ELECTROMECHANICAL COUPLING AND DISEASE MECHANISMS OF MYOCARDIAL CNBD FAMILY CHANNELS

PROJECT SUMMARY/ABSTRACT
The CNBD family of channels, encompassing hyperpolarization-activated cyclic nucleotide-gated (HCN) and
depolarization-activated KCNH members, plays a pivotal role in shaping the electrical properties of the heart.
The modulation of HCN channels presents a promising therapeutic avenue for the management of atrial and
ventricular arrhythmias by influencing the activity of the sinoatrial node pacemaker. In addition, the human
KCNH2 potassium channel (hERG) gene is linked to long QT syndrome (LQTS), an inherited cardiac condition
that substantially escalates the risk of ventricular arrhythmias and sudden cardiac death. HCN and KCNH
channels share structural features, most notably their voltage-sensing domains (VSD). However, they display
divergent channel gating behaviors. Up to this point, a comprehensive mechanism that adequately explains the
diversity in their voltage-dependent gating has remained elusive. In particular, the VSD of HCN channels
undergoes distinct conformational changes during activation, whose dynamics, nature of intermediate
conformational states, and couplings to other domains remain largely uncharacterized. Moreover, like mutations
affecting the VSD of HCN channels, we recently uncovered that several LQTS-linked mutations the S4 helix
voltage sensor of hERG channels lead to distinctively altered voltage-dependent activation profiles. The
underlying mechanism of these disease-causing gating alterations remains unexplored, yet it is central to our
understanding of the mechanism of cardiac diseases related to CNBD channels. The overarching objective of
this application is to determine the VSD dynamics of recombinant CNBD channels expressed in human cell lines,
using an array of concerted biophysical techniques. We will improve the patch-clamp fluorometry (PCF) method
to study the structure-function correlation of cardiac voltage-gated channels, paving the way to new treatments
of myocardial diseases. Our primary goals also include studying how pivotal regulatory domains modulate
channel gating by altering VSD conformations. To quantitatively assess voltage-dependent structural
rearrangements, we will leverage transition metal ion Förster resonance energy transfer (tmFRET), noncanonical
amino acid integration, and click chemistry for site-specific fluorescence labeling. This strategy will enable us to
precisely translate FRET efficiencies into interatomic distances. In parallel, phasor-plot fluorescence lifetime
imaging (FLIM) in conjunction with molecular dynamics (MD) simulations will be used to quantify the underlying
structural dynamics. Collectively, the proposed studies will delineate the energetics, allostery, and structural
foundations of cardiac pacemaking ion channels.

Public health relevance
PROJECT NARRATIVE The primary goal of this application is to understand how a crucial family of cardiac voltage-activated cation channels sense membrane voltage, which will potentially lead to new targets of treatment for heart diseases especially arrhythmias. Using advanced electrophysiology and fluorescence imaging methods, our experiments will provide mechanistic insights into disease-associated mutations of this family of ion channels and strategies for cardiac arrhythmia therapy.